Evaluating risk of diagnostic delay in peripartum cardiomyopathy

PROJECT SUMMARY
Black women are three times more likely to die as a result of pregnancy compared to White women in
the US and are more likely to die from cardiovascular (CV) disease, including peripartum
cardiomyopathy (PPCM). PPCM is a condition of new onset heart failure in the weeks to months after
delivery in women without pre-existing CV disease. Black women are more likely to develop PPCM,
less likely to recover, and have a higher mortality rate compared to White women. Strategies to
improve early detection and treatment of PPCM hold promise to substantially reduce disparities in
maternal deaths. Prior work has demonstrated that Black women are diagnosed with PPCM later in
the postpartum period and that delayed PPCM diagnosis is associated with worse clinical outcomes.
The primary purpose of this application is to determine the patient, provider, and practice
(health system) factors that drive delays in PPCM diagnosis and to develop a pragmatic
intervention to overcome these barriers. We will focus directly on the patient and provider
experience to understand mechanisms of delays, which have not been researched in prior PPCM
studies. We have the unique opportunity to collect patient-reported data from patients with recently
diagnosed PPCM referred from the PPCM Consortium, a geographically diverse network of 60 sites
across the US. We propose a mixed methods study to accomplish the following aims. First, we will
determine the patient-reported factors contributing to delayed PPCM diagnosis using in-depth
interviews and patient surveys and compare how these factors differ for Black and White women.
Next, we will determine the provider and practice factors contributing to delayed diagnosis by
conducting interviews and surveys with providers from specialties responsible for diagnosing PPCM,
including obstetrics, primary care, and emergency medicine. We will then work with our stakeholder
advisory board, consisting of patients with lived experience of PPCM, community members,
cardiologists, obstetricians, and experts in public health and health equity to develop an intervention
to reduce disparities in PPCM diagnosis and test the feasibility of the intervention among patients and
providers at five clinical sites. Developing scalable interventions to improve timely diagnosis and
treatment of PPCM has the potential to improve short and long-term maternal CV outcomes and may
be generalizable to CV disease diagnoses in women unrelated to pregnancy.

Public health relevance
PROJECT NARRATIVE Peripartum cardiomyopathy (PPCM) is a leading cause of maternal death in the postpartum period and disproportionately affects Black women, contributing to the profound racial disparities in US maternal mortality rates. Delayed PPCM diagnosis is associated with worse outcomes and contributes to racial disparities. The primary purpose of this proposal is to determine modifiable patient, provider, and health system factors that drive delays in PPCM diagnosis and to develop an evidence-based intervention that aims to improve quality of care and reduce disparities in maternal morbidity and mortality for women with PPCM.